Elucidating the mechanism and correlates of protection elicited by CDN adjuvanted vaccines for M. tuberculosis.

Project Summary
Mycobacterium tuberculosis (Mtb) is leading cause of death worldwide by a single infectious agent. In 2023,
approximately 10.8 million people fell ill with tuberculosis (TB) and 1.25 million people died.1 The only
licensed vaccine available, Mycobacterium bovis Bacillus Calmette-Guerin (BCG), has limited efficacy that
wanes over time and fails to protect against adult pulmonary TB or impede TB transmission.3 Efforts to
develop new and effective TB vaccines have remain unsuccessful primarily due to our lack of understanding
of the immune responses that mediate TB protection. The persistence of the TB pandemic and the absence
of an efficacious vaccine for preventing TB disease emphasize the urgent need to further understand
mechanisms and immune correlates of protection to TB that can help guide the design of novel vaccines. The
use of experimental vaccines that elicit protection against Mtb challenge in animal models could lead to
insights into adaptive immune mechanisms that are important for protection against Mtb infection. We
recently demonstrated that intranasal (i.n.) vaccination with the experimental vaccine H1/CDN provides
remarkable protective efficacy against infection with Mtb in the mouse model. This protein subunit vaccine
consists of H1 Ag, a fusion of two highly immunodominant Mtb protein antigens (Ag85b and ESAT-6), and
the STING activating adjuvant cyclic-di-nucleotide (CDN) ML-RR-cGAMP (H1/CDN). While we have shown
that IL- 17 and IFN-γ producing CD4 T cells are required for CDN adjuvanted vaccine efficacy, the precise
phenotypes and localization of Th1 and Th17 cells required for protection are still unclear. In addition, the
specific cell types that respond to IL-17 during vaccination and Mtb challenge and the role of IL17 in their
activation and recruitment remain unknown. Furthermore, the mechanism by which STING activation leads
to increased protection also remains elusive. In this project, our goal is to investigate the mechanisms and
correlates of protection elicited by CDN adjuvanted vaccines for tuberculosis. In Aim 1, we will determine how
spatial localization and trafficking of Th1 and Th17 cells impacts vaccine efficacy. In Aim 2, we will determine
the role of IL-17 in the recruitment, spatial localization, and phenotypes of both epithelial and innate and
adaptive immune cells necessary to confer vaccine-elicited protection. Finally in Aim 3, we will determine
whether STING mediated autophagy contributes to CDN adjuvanted vaccine efficacy. Together these results
will provide a better understanding of the mechanisms underlying CDN vaccine protection and inform the
development of more effective vaccines against Mtb.

Public health relevance
Project Narrative Mycobacterium tuberculosis (Mtb) is the leading cause of death worldwide by a single infectious agent, yet efforts to develop an effective vaccine for tuberculosis have remained unsuccessful due to a lack of understating of the mechanisms of immune mediated protection. Recently, the efficacy of cyclic-di-nucleotide (CDN) adjuvanted vaccines against Mtb has been discovered, however the precise mechanisms by which STING activation leads to enhanced protection remain unclear. This study aims to elucidate the mechanisms driving CDN vaccine protection with the goal of informing the development of more effective vaccines against Mtb.